Targeting Bacterial Signaling Cascades as a Novel Antibiotic Strategy

Background and Veteran significance: Pathogens such as mycobacteria and Staphylococcus aureus, are
not only intrinsically antibiotic resistant, but are rapidly acquiring multi-drug resistant traits. Two billion people
are currently infected with Mycobacterium tuberculosis, and an increasing proportion are resistant to clinical
treatments. Methicillin resistant Staphylococcus aureus (MRSA) is a massive burden in healthcare, and
vancomycin resistant strains are increasingly problematic. These resistant infections are endemic to
developing countries and areas with a regular military presence, causing an increased burden for the Veterans
Administration healthcare system. Furthermore, MRSA infections are a major concern in VA hospitals and
are a significant cost in time, resources, and lives. New effective antibiotics are needed, and development
against novel targets is needed to treat infections caused by these resistant organisms.
Novel antibiotic targets: Protein kinases and phosphatases are critical in transducing cellular and
environmental signals to trigger growth and division or to respond to stress and environmental changes.
Human phosphorylation signaling is well studied, but bacterial signaling is less known and no antibiotics
targeting these pathways exist. Penicillin-binding And Serine/Threonine Associated (PASTA) kinases are
unique transmembrane kinases present in Actinobacteria and Firmicutes. PASTA kinases are necessary for
virulence, making them attractive drug targets. Genetic knockouts in MRSA and pharmacological inhibition in
MRSA or tuberculosis increase β-lactam susceptibility. Furthermore, genetic deletion of the cognate S/T
phosphatase in MRSA increases this synergy and decreases in vivo virulence. Inhibiting both kinases and
phosphatases to enhance β-lactam synergy is a novel approach to antibiotic development.
Goals of this award: The goals of this award are to 1) provide time and resources to facilitate Dr.
Wlodarchak’s transition from a mentored scientist to an independent translational investigator in the VA
system and to 2) develop lead compounds against novel antibiotic targets in MRSA and tuberculosis. The
central hypothesis tested here is that a coordinated attack on several nodes of the serine/threonine
phosphorylation signaling cascade will be an effective pharmacological strategy with low likelihood
of resistance development. This hypothesis will be tested by characterizing hits from a biochemical
phosphatase screen, developing MRSA kinase inhibitors, and performing the first global transcriptomic and
phosphoproteomic screen on MRSA under pharmacologic stress on this pathway.
Expected outcomes and impacts: Upon completion of this award, it is expected that Dr. Wlodarchak will
transition to a fully independent VA investigator with several well-characterized lead compounds against
MRSA and tuberculosis and leads on other potential targets in this pathway. This research will provide
preliminary data for a competitive VA Merit award for a translational drug development project. This will have
a positive impact on not only Dr. Wlodarchak’s career but also on Veterans’ health by providing mechanistic
insight on how phosphorylation signaling controls virulence and by providing tangible compounds that may
become clinical drugs. This will help provide options to stifle the current antibiotic resistance crisis and thus
improve patient survival and quality of life.

Public health relevance
Bacterial infections are a major public health burden and antibiotic resistant bacteria are increasingly difficult to treat with available drugs. Antibiotic development is stagnant and new classes of drugs are desperately needed. Methicillin resistant Staphylococcus aureus (MRSA) and tuberculosis are a major global concern and disproportionately affect Veterans. Tuberculosis is endemic to many regions with a regular military presence, and MRSA is rampant in VA hospitals at home with treatments being costly and often ineffective. Both military occupational exposures and clinical burdens are a CSR&D priority research area. This proposal aims to develop new drugs against novel bacterial mechanisms and establish Dr. Wlodarchak as a translational VA scientist in drug discovery and development. Successful completion of this work will have a positive benefit on understanding how these drugs act on novel bacterial targets and provide drugs for further clinical development. This is an important step to reduce the burden of these diseases on Veteran health.